The Pacific Ocean Native Observational (PONO) Health Legacy Study

PROJECT SUMMARY
Hawai‘i is the most ethnically diverse state in the US. Native Hawaiians (NH), Pacific Islanders (PI) and Asian
Americans (AsA) account for nearly 70% of the state’s population & it is home to >50% of all NHPI in the US.
This UG3/UH3 proposal will establish a new prospective, multi-generational cohort to investigate
cardiopulmonary & metabolic (CPM) health among NH & Micronesian PI in Hawai‘i. These 2 distinct, yet
understudied, sub-populations have an excess burden of CPM disease outcomes. Diabetes mellitus (DM)
occurs in 28% and preDM in 37% of NHPI (>20y.o.), suggesting >50% of NHPI have or are at-risk for DM.
CVD mortality is 4-fold higher in NHPI with DM compared with nonDM. CVD mortality is the leading cause of
death among NHPI. Despite decades of clinical & intervention studies among NHPI, CPM health inequities
remain largely unchanged & is increasing among younger NH and PI people. Our proposal, the Pacific Ocean
Native Observational (PONO) Health Legacy Study, will directly confront methodological challenges (i.e.
racial aggregation, small sample size, etc.) of prior NHPI studies & will conduct innovative, technology-driven
“populomics” approaches to change the course of CPM health disparities among NH & PI. Our approach builds
on a strong interdisciplinary team of scientific & community-based leaders who bring decades of community,
clinical, epidemiological & epigenomic expertise. We will work closely with the Coordinating Center to
maximize the overall AsA-NHPI cohort’s ability to conduct studies of multiple hypotheses testing. Our specific
aims (S.A.) are as follows:
S.A.#1 (UG3): Establish a prospective, community-engaged, multi-generational population-based
cohort study of 2,500 Native Hawaiians and Pacific Islanders in Hawai‘i. Our longstanding partnerships
with clinical & community-based groups are primed & enthusiastic to recruit, retain & conduct standardized
data & biological specimen collection that will invest in the health of future generations.
S.A. #2 (UH3): Characterize the relationship of risk and resilience factors with clinical blood-based
biomarkers of metabolic and immunologic function relevant to CPM conditions. Determine prevalence of
CPM subclinical disease & conduct association studies of multi-level risk & resilience factors by CPM
conditions.
S.A. #3 (UH3): Assess the impact of CPM-associated risk and resilience factors on incident CPM-
outcomes measured over time between Hawai‘i and continental populations of NH and PI in the AsA-
NHPI cohort study. Determine incidence of CPM outcomes associated with multi-level risk/resilience factors &
to compare data with relevant subpopulations in the overall AsANHPI cohort.
The overall impact of the PONO study is its potential to transform health disparity research through
novel “populomics” approaches in a representative population of AsANHPI in the US.

Public health relevance
PROJECT NARRATIVE The PONO study will establish a new prospective, multi-generational cohort on cardiopulmonary and metabolic health among the understudied sub-populations of Native Hawaiians (NH) and Micronesian Pacific Islanders (PI). The long term goal of the study is to use novel “populomics” research approaches to unravel the complexities of health inequities and contribute to the larger cohort of 10,000 Asian Americans-NH-PI aimed at filling a gap in understanding of CPM health disparities between and within these heterogenous populations compared with the general US population.